Phytobacterial lipopolysaccharides in Juzen-taiho-to

Microbial drug resistance is a serious threat to the global health. It is essential to explore new anti-infective
strategies that avoid the emergence of new drug resistance. One promising approach is the host-directed
immunotherapy, which aims at boosting the innate immunity to prevent/treat infectious diseases. The approach
avoids the emergence of resistance by targeting the host instead of the pathogen. Several host-directed
immunotherapeutics are currently in clinical use, including monophosphoryl lipid A (MPL), which is used as a
vaccine adjuvant. While the concept is promising, there is one major challenge in the development of new
immunotherapeutics. Stimulation of the innate immunity activates the signaling pathways for inflammation as
well as for protective immunity. Although inflammation is important for rapid eradication of invading pathogens,
its hyperactivation can be very harmful to the host. Thus, the challenge is how to control inflammation without
compromising protective immunity. To find a new approach to safely promote protective immunity, the
proposed SC3 project will examine Juzen-taiho-to (JTT), an immune-boosting herbal formulation with long-
tested clinical efficacy and safety. Recently, our group found that the immunostimulatory activity of JTT arises
from lipopolysaccharides (LPSs) of plant-associated bacteria. Since LPSs are pro-inflammatory toxins, JTT
must have a mechanism to effectively control the pro-inflammatory pathway. The objective of the proposed
SC3 project is to clarify the mechanism by which pro-inflammatory effect of LPSs is controlled in JTT. The
central hypothesis is that the pro-inflammatory effect is controlled by dual mechanisms, namely, (1) the LPSs
in JTT, which is administered orally, are hydrolyzed by the stomach acid to benign forms that can still promote
protective immunity, and (2) anti-inflammatory phytochemicals in JTT selectively attenuate the pro-
inflammatory effect without compromising protective immunity. Both of these mechanisms are based on our
strong preliminary results. To accomplish the objective, the following aims will be pursued. Aim 1: Characterize
the structures and immunological effects of acid-treated LPSs in JTT. A combination of mass spectrometry
cell-based assays, and in vivo cytokine profiling will be employed to characterize the impact of acid-treatment
on the structures and immunological effects of phytobacterial LPSs. Aim 2: Determine the roles of anti-
inflammatory phytochemicals in JTT. Here, anti-inflammatory phytochemicals will be subjected to cell-based
assays and in vivo cytokine profiling to determine their effects on inflammation and other immunological
pathways. It is our expectation that the proposed work will reveal a time-tested, but hitherto uncharacterized,
approach to generate safe immunotherapeutics, which will expand our ability to develop new anti-infective
strategies that avoid microbial resistance. The developmental objective of the PI is to build a strong
collaborative research program focused on the discovery of novel immunomodulatory agents. Based on the
results obtained from the proposed SC3 project, the collaborative team will aggressively seek extramural
funding for future studies.

Public health relevance
The proposed research will characterize immunomodulatory molecules that exist in an herbal formulation with a long record of clinical safety and efficacy. Characterization of these molecules will pave the way to develop new host-directed immunotherapeutics, which are chemical agents to boost our natural ability to prevent/treat infectious diseases, including those caused by drug resistant microbes.